INTERMITTENT GLYBURIDE AND GLIPIZIDE THERAPY IN TYPE II DIABETICS

The objectives of this study are to (1) determine the efficacy of alternate day therapy with glyburide or glipizide in the management of type II diabetics with secondary sulfonylurea failure; (2) compare insulin sensitivity and beta-cell function in patients on alternate day versus daily therapy; and to compare the effect of different modes of sulfonylurea therapy on substrate utilization.